Image-guided intra-arterial delivery of stem cells to repair brain damage after TBI

It is estimated that traumatic brain injury (TBI) accounts for over 2 million emergency department visits per
year, and nearly 300,000 require hospitalization and treatment (CDC data). Those who serve in the military are
at significant risk for TBI, with 414,000 cases reported among US service members between 2010-2019.
Consequences of TBI are often severe, including suffering for the victim, lost productivity, and burden on public
health systems, with the costs of hospitalization and rehabilitation growing, as well as current inadequate
treatments. Unfortunately, many patients develop lifelong neurological deficits. As the understanding of the
pathomechanism of TBI increases, attractive therapeutic targets are identified. Hence, there is hope of
developing new therapeutic strategies that could be implemented early to halt the ongoing cascade of damage
and at later stages, afford repair of brain damage.
Pathomechanism of TBI is complex with multiple factors contributing to neurological deficits. TBI
triggers a strong and immediate inflammatory insult, with so-called “danger signals” or danger-associated
molecular patterns (DAMPs) being potent activators of local immune responses, mediating secondary brain
damage - especially adenosine triphosphate (ATP) and its receptor, P2X purinoceptor 7 (P2X7), whose
blocking has been studied with some success. However, following systemic administration, accumulation of
these macromolecules in the brain is hugely ineffective. Over the last two decades, our research has focused
on improving brain targeting with intra-arterial route being the most effective - as it facilitates minimally invasive
administration of high concentrations of drugs with immediate access within the entire lesion. Indeed, we
confirmed experimentally that even during acute stage after TBI intraarterial targeting of brain lesion is feasible.
This approach is ideal to address the needs of preventing TBI damages in the acute phase. As for the chronic
effects of TBI, recent studies focusing on war Veterans with TBI have revealed a preponderance of white
matter abnormalities.
Our group has worked extensively with glial restricted progenitor (GRP) cells; and we demonstrated
quite spectacular therapeutic effects following transplantation in dysmyelinated mice. We have shown that
intra-arterially delivered GRPs can cross the blood-brain barrier; and thus, serve as a carrier for the local
production of neuroinflammation-blocking nanobodies in brain parenchyma. Here we propose the “block-and-
repair” therapy to address both the acute phase inflammation and the chronic phase white matter damage after
TBI. In this strategy, GRPs will be bioengineered with mRNA encoding a potent P2X7 nanobody to be
secreted in situ to block inflammation, and GRPs will mature to repair white matter injury after TBI. To improve
brain targeting for immediate effect, we will inject the cells using our established image-guided intra-arterial
technique. Our previous work showed functional improvement after TBI by depletion of microglia. In this
proposal, we will explore if there is any additive effect with combined microglial depletion and P2X7nb-mRNA-
GRPs. Overall, we propose an innovative cell-based strategy that addresses both acute and chronic
pathomechnisms following TBI. If our project demonstrates safety and efficacy of this approach, it could be
rapidly implemented into clinical practice- potentially impacting the treatment of TBI.

Public health relevance
Traumatic brain injury (TBI) is a devastating condition with limited treatment options. Incidence and long-term consequences of TBI disproportionately burden Veterans. This project aims at improving prospects for Veterans and other TBI victims through reducing both initial brain damage as well as repair of chronic abnormalities in white matter. Neuroinflammation is a major contributor to acute secondary damage, and white mater loss exacerbates the injury over the long term. We propose to address these two aspects by intra- arterially transplanting glial progenitor cells, engineered to express Nanobodies, selectively blocking neuroinflammation-inducing danger signals. Over the last two decades our research has focused on improving therapeutic agents targeting the brain with an intra-arterial route facilitating minimally invasive administration of high concentrations of drugs with immediate access within the entire lesion.